ANCHOR Correlative Science Administrative Supplement

7. Project Summary / Abstract
The ANCHOR Study is an ongoing, longitudinal, multicenter trial in people living with HIV
(PLWH), which demonstrated that treating anal high-grade squamous intraepithelial lesions
(HSIL, or precancer) prevents progression to anal cancer, as compared to active monitoring
(six-monthly high-resolution anoscopy exams with biopsies and cytology). This trial was a
unique opportunity to conduct a randomized study comparing monitoring to treatment, the utility
of which had not yet been established as effective and therefore not considered standard care.
As part of the trial, we collected serial samples to establish a biobank, and therefore a unique
opportunity to conduct comparisons in participants who did and did not progress to cancer. Our
aims with this supplement are to initiate the trial’s correlative science objectives to inform HSIL
screening algorithms for secondary prevention of anal cancer, optimize use of HRA and HSIL
treatment resources by identifying biomarkers of HSIL regression, and explore the molecular
pathogenesis of progression from HSIL to anal cancer. Findings from this research, among
other assays, are intended to inform optimal screening and treatment strategies for anal cancer
prevention in PLWH and potentially other groups.

Public health relevance
8. Project Narrative The ANCHOR Correlative Science Supplement will conduct a cross-sectional HPV genotyping analysis to create a comprehensive profile of HPV type distribution in PLWH and identify optimal screening algorithms to identify those at risk of anal HSIL and cancer; analyze serial specimens from randomized participants to identify biomarkers of spontaneous HSIL regression to normal; process anal cancer and preceding HSIL biopsy specimens to create a foundation for future studies of molecular pathogenesis of progression from HSIL to cancer; and initiate exploratory tissue analyses preparatory to analyzing randomized cancer cases.